IMPAKT Study: Imaging Modalities in Pediatric Assessments of Kidney Transplants

PROJECT SUMMARY/ ABSTRACT
The overarching objectives of this proposal are to investigate whether novel quantitative MRI and ultrasound
imaging parameters can reliably detect kidney transplant injury that indicates risk of allograft failure in children.
Children with end-stage kidney disease (ESKD) have a mortality rate 30 times higher than children without it. As
kidney transplantation provides a significant survival advantage over dialysis, children with ESKD often require
multiple kidney allografts over their lifespan. Each transplant increases surgical, immunological, and oncogenic
risk. Kidney allograft injury results from inflammatory, infectious, vascular, and fibrotic changes that can
ultimately result in allograft failure. A major limitation to promoting long-term allograft survival is the lack of non-
invasive diagnostic and prognostic biomarkers to reliably detect early injury in the allograft. This proposal seeks
to develop magnetic resonance imaging (MRI) and contrast-enhanced ultrasound (CEUS) biomarkers to
measure inflammation of kidney transplant in children. Currently, kidney allograft biopsy is the gold standard to
diagnose such changes, but is invasive and not free of complications, which limits its use. Identifying such
markers will allow us to implement individualized interventions to improve allograft survival and decrease
unnecessary biopsies. Aim 1 will determine advanced MRI and CEUS parameters that associate with
histopathological total inflammation Banff score and Chronic Allograft Damage Index (CADI) score. Aim 2 will
identify novel MRI and CEUS parameters that predict change of eGFR in pediatric kidney transplant recipients
at 6-24 months post-transplantation. The results will inform the field of novel non-invasive imaging biomarkers
in pediatric kidney transplantation. Complementary to this investigation I plan to acquire further training in 1)
conventional and CEUS research imaging acquisition and analysis, 2) MRI research data acquisition and
analysis, 3) design and implementation of biomedical imaging based patient-oriented research studies, and 4)
acquire leadership skills through a professional development plan in the rigorous research environment of
Children’s Hospital of Philadelphia and University of Pennsylvania. To accomplish these goals, I have assembled
a multi-disciplinary mentoring/advisory team of experts in clinical nephrology patient-oriented research (Primary
mentor, Susan Furth, MD, PhD), MRI clinical and translational research studies (Timothy Roberts, MD, PhD;
Suraj Serai, PhD), CEUS (Chandra Seghal, PhD; Susan Back, MD; Anush Sridharan, PhD), pediatric kidney
transplantation biomarkers (Sandra Amaral, MD, MHS), multinational collaborative networks (Gregory Tasian,
MD, MSCE), kidney disease statistical methods (Jarcy Zee, PhD), and patient-oriented imaging research (Kassa
Darge, MD, PhD; Erum Hartung, MD, MSTR; Hansel Otero, MD). The proposed research, along with the
structured mentoring, coursework, and training that comprise my career development plan, will provide me with
the skills and experience necessary to ensure my success as an independent investigator with a unique skill set
in developing imaging biomarkers for kidney transplantation.

Public health relevance
PROJECT NARRATIVE To improve pediatric kidney transplant survival, we propose to investigate how non-invasive MRI and contrast- enhanced ultrasound imaging biomarkers may detect and predict allograft injury at-risk of failure. This research is highly relevant to public health as it targets improving long-term health outcomes globally by validating more accessible imaging technology and enhancing personalized management based on individual imaging patterns of kidney transplant dysfunction; imaging as surveillance tool to assess allograft health.